Shared Resource Management

ABSTRACT: SHARED RESOURCE MANAGEMENT
The Lineberger Comprehensive Cancer Center has a strong history of providing high quality and cost-effective
shared resources that offer innovative services and technologies to the membership. The oversight of the SRs
involves the Director, Deputy Director, and Associate Directors of the Center. Program leaders also provide
valuable input and guidance on the services offered. Center members provide feedback through surveys and
serve on SR active internal advisory boards for each SR. Over the last five years, this management process
has provided substantial new infrastructure for the faculty including: 1) an expanded and more robust tissue-
based research pipeline for correlative work, 2) new technologies such as single cell analysis, mass spec
cytometer instrumentation, and a CyroEM, 3) expanded faculty SR leadership expertise in pathology and
biostatistics. The financial and administrative oversight is provided by the Associate Director of Administration
and his staff of 4 FTEs devoted to this endeavor. The SRs are well managed and are well used as
demonstrated by these statistics:
• 97% of 2018 user-survey respondents stated the SR overall experience was excellent or good.
• 81% of LCCC Members used a Shared Resource in FY19
• 82% of FY19 total LCCC managed-Shared Resource users were Center faculty
Importantly, the SRs are cost-effective and provide exceptional value to the members. The Center requests
8% of the operating budget for the SRs from the CCSG. This is greatly leveraged through a sustained annual
institutional commitment of over $10M in operational support, 37% of the total SR operating budget. The
remaining SR operating budget, approximately $14.3M, is recovered by recharge mechanisms. As a result of
the CCSG and institutional commitment, members receive discounts on fees, priority access and free
consultative services.